Molecular Regulations of Mitochondrial Structure in Neuronal Homeostasis and Survival

Mitochondrial malfunction is well known to manifest as dysfunction of neurons, due to the high
energetic demands of these highly polarized cells, their remarkable axonal length, and complexity.
However, how neuronal mitochondria precisely control crista structure in response to ever-
changing energy demands and oxidative stressors and how these regulations impact neuronal
function and behavior in multicellular organisms remain elusive. In our Preliminary Studies, we
have discovered an evolutionarily conserved role for MIC60 in maintaining crista structure in
Drosophila. We have found molecular modifications of fly MIC60 (dMIC60) including
phosphorylation and oxidation and their significance in maintaining crista junction plasticity and
resisting oxidative stress. These results demonstrate the vital importance of dMIC60 and its
posttranslational modifications for mitochondrial and neuronal homeostasis. We hypothesize that
molecular regulations of dMIC60 including phosphorylation and oxidation allow dMIC60 to receive
cellular signals to conduct its functions and that their misregulations could lead to neuronal
dysfunction and degeneration. To test this hypothesis, we will perform the following Specific Aims.
Aim 1: Roles for dMIC60 in neuronal homeostasis. Aim 2: Crista structure as a cellular
cause for oxidative damage. Aim 3: Molecular mechanisms of dMIC60 phosphorylation and
oxidation.

Public health relevance
Relevance Disruptions of mitochondrial structure have been found in many neurodegenerative and mitochondrial diseases which afflict millions of people worldwide with tremendous global economic and societal burdens. An effective treatment is desperately needed but the underlying molecular and cellular mechanisms of their destructive path remain poorly understood. This proposal aims to elucidate the mechanisms underlying mitochondrial strucutral maintenance and provide novel therapeutic strategies to alleviate oxidative damage, is therefore relevant to public health and the mission of the NIH.